Novel functions of RGS3

DESCRIPTION (provided by applicant): Regulator of G protein signaling RGS3 is a GTPase-activating protein (GAP) that binds G-alpha subunits of heterotrimeric G proteins and accelerates their GTPase activity. We and others have shown that through this mechanism, RGS3 regulates the signaling of Gq- and Gi-coupled receptors to angiotensin II, endothelin-1, carbachol, gonadotropin-releasing hormone and sphingosine-1 phosphate. Our new data suggest that a) RGS3 interacts with the transducers of TGF-2 signaling, Smad transcription factors that were previously thought to be unrelated to G protein / RGS axis;b) RGS3 inhibits Smad-mediated gene transcription;and c) RGS3 is abundant in T-lymphocytes and its expression in T cells is further induced by TGF-2 treatment. In T cells, G protein signaling is associated with migration towards various chemokines, whereas TGF-2 signaling controls proliferation and differentiation of T cells at multiple levels. The function of endogenous RGS3 has not been investigated in T cells. Based on our preliminary data, we hypothesize that (i) RGS3 is a multifunctional protein that, in addition to regulating G protein signaling, also modulates the signaling of TGF-2, and (ii) endogenous RGS3 controls T cell migration, proliferation and differentiation through the regulation of both G protein- and TGF-2 signaling. To test these hypotheses, we propose three specific aims: (i) investigate the molecular nature and functional consequences of RGS3 / Smad interaction by overexpression of RGS3 and its mutants, (ii) investigate the regulation of G protein- and TGF-2 signaling by endogenous RGS3 in EL4 T thymoma cell line;and (iii) examine how RGS3 controls T cell migration, proliferation and differentiation in response to TGF-2 and chemokines, using T cells from RGS3-knockout mouse. The fundamental significance of this study relates to a potential discovery of a novel, non-canonical function of RGS3 as a regulator of TGF-2 signaling. The practical importance of this study relates to understanding the diseases associated with abnormal immune responses of T cell. PUBLIC HEALTH RELEVANCE: Appropriate function of T lymphocytes is critical for the adaptive immunity, whereas abnormal function of T cells leads to autoimmune and inflammatory diseases such as asthma, multiple sclerosis, rheumatoid arthritis, type I diabetes and others. Therefore, defining the molecular mechanisms of T cell activation and differentiation may lead to a better understanding the pathogenesis of these diseases.

Public health relevance
Project Narrative Appropriate function of T lymphocytes is critical for the adaptive immunity, whereas abnormal function of T cells leads to autoimmune and inflammatory diseases such as asthma, multiple sclerosis, rheumatoid arthritis, type I diabetes and other. Therefore, defining the molecular mechanisms of T cell activation and differentiation may lead to a better understanding the pathogenesis of these diseases.